Behavioral and axonal impacts of thalamic microglial process convergence following diffuse brain injury

Project Summary
Traumatic brain injury (TBI) can lead to significant morbidities that are altered by changes in inflammatory state.
Microglia, the innate immune cells of the brain, are critical mediators of neuroinflammation that can have either
neurotoxic or neurotrophic effects. To date, these effects have been examined primarily in rodents, while their
parallel consideration in humans has not yielded clinically translatable findings, suggesting potentially different
responses in higher order mammals. The pig is an ideal pre-clinical translational animal model, due to its
similarities to humans in cytoarchitecture, metabolic rates and systemic inflammatory responses, however, only
a handful of TBI research centers are using pig models of brain injury and currently none are focused on the
interaction between microglia and injured axons or pathology within the thalamic domain. Our preliminary data
demonstrated that microglial processes converge onto injured axonal swellings (microglial process convergence;
MPC) in the thalamus of micro pigs, that is not recapitulated in rats, following diffuse TBI. Increased sensitivity
to sensory stimulation and anxiety are associated with TBI and inflammation, unfortunately, the limited use of
behavioral assessments in pig models of TBI leaves the link between post-injury MPC and behavioral outcomes
unclear. Both our preliminary data and previous studies indicate that MPC may be an ameliorative process,
promoting axonal outgrowth post-injury with the caveat that aberrant axonal outgrowth is linked to heightened
behavioral morbidity. Therefore, the goal of this study is to assess the role of MPC on neurite outgrowth
and behavioral morbidity in a pig model of diffuse TBI and gain insight into the similarity to human
pathology. Studies indicate that males have greater pro-inflammatory responses, less axonal outgrowth, and
reduced sensory sensitivity and anxiety compared to females. However, there are no known studies evaluating
MPC in both males and females. Accordingly, the current study will address the following specific aim 1) To
elucidate the extent and role of microglial process convergence on axonal outgrowth and behavioral
morbidity following diffuse TBI. To address this aim we will complete quantitative 3D assessments of
multiplexed immunohistological samples for microglial-axonal interactions/MPC in pigs to determine the degree
and progression of MPC in relation to sensory sensitivity and anxiety/social interaction changes, axonal
outgrowth/retraction changes in both sexes within the first week post-injury. This study is significant because it
will provide valuable preliminary data regarding 1) the duration and extent of MPC in a gyrencephalic pig model,
2) the behavioral dysfunction(s) associated with thalamic MPC, and 3) the sex-associated differences in MPC.
These studies will serve as a springboard for future investigations into 1) the potential adaptive and/or
maladaptive role of various degrees of MPC 2) the molecular mechanisms involved in and potential therapeutic
modulation of MPC and 3) investigations regarding the therapeutic modulation of TBI-mediated sensory
sensitivity and/or anxiety.

Public health relevance
Project Narrative Traumatic brain injury (TBI) effects millions of people annually and can lead to significant long-term problems which can be impacted by alterations in neuroimmune responses. Microglia, the innate immune cell of the brain, are critical mediators of neuroinflammatory processes, which are initiated by TBI, however, little is known regarding microglial process interactions with injured axons following brain injury. This study aims to investigate the extent and role of microglial process convergence onto injured axons following diffuse TBI in a higher order pig model, particularly as they relate to axonal and behavioral changes.